Enhancer AAV toolbox for cell classes and subclasses in the brains of mouse, macaque and marmoset.

Project Summary
We propose to create, screen, characterize, and distribute (through one or more non-profit partners) a large set
of recombinant adeno associated virus (AAV) tools to target the cell classes, subclasses, and select types in the
mouse, marmoset and macaque brains. We propose to leverage our new whole mouse brain (WMB) single-
nucleus multiome dataset to nominate mouse enhancers for classes and subclasses in the mouse brain. We will
employ a second-generation enhancer discovery, screening and characterization pipeline to evaluate at least
2000 enhancers in mouse, 100 in macaque and 30 in marmoset. The characterization of enhancer virus
specificity and labeling completeness will be carried out in mouse with a tri-modal pipeline: WMB light sheet
imaging, WMB 10xFlex sn-transcriptomics, and spatial transcriptomics on select sections with BARseq. The
enhancers with desirable expression patterns will be modified to increase expression strength through enhancer
core concatenation and tested for driving different cargos (e.g., Cre recombinase). The characterization of
enhancer specificity in macaque and marmoset will rely on BARseq for the injected brain regions at the level of
class and subclass, and where feasible, supertypes. In parallel with the brain-wide enhancer AAV discovery, we
will conduct a focused enhancer AAV discovery at fine cell-type granularity for midbrain dopaminergic neuron
types and subtypes with emphasis on cross-species validation and conservation. These cell types are key
players in the brain circuits of reward, motivation, and motor control and the tools discovered here could be
applicable to addressing circuit dysfunction in basal ganglia disorders. If successful, this award will establish an
unprecedented mammalian brain toolbox showcasing both a broad brain-wide approach and a focused cell-type
approach for the neuroscience community with reagents, characterization data and protocols for use available
to all. The deliverables from this award could have a transformative effect on cell type characterization in the
mammalian central nervous systems, from measuring various properties of cell types to defining their function
and the detailed understanding of structure-function relationships in mammalian brains, and potentially,
development of cell type-specific therapeutics for brain disorders.

Public health relevance
Project Narrative We propose to employ a standardized trimodal Allen Institute pipeline for (1) cell-class and subclass-specific enhancer adeno-associated virus (AAV) vector tool discovery for the whole mouse brain based on whole-mouse brain single-nucleus multiome data, (2) further evaluate 100 curated enhancer AAVs in macaque and select enhancers in marmoset, (3) explore fine-targeting of dopaminergic neuron types in mouse, marmoset and macaque, and (4) distribute all data, procedures, protocols and reagents to the community through the Allen Institute web portal and non-profit partners. This grant will execute an integrated scalable AAV tool development and distribution process for all major cell types and regions of the mammalian brain.